Stress Exacerbates Myocardial Ischemic Injury by Blocking Estrogen's Antidoxidant Protection in the Female Heart

PROJECT ABSTRACT
The psychological stress associated with the COVID-19 pandemic has led to an unprecedented increase in
stress disorders. High-stress levels closely correlate with clinical depression and cardiovascular disease. In
contrast to men, women are more reactive to the cardiovascular effects of mental stress. In particular, young
women have a higher susceptibility to the harmful effects of stress, and increased stress levels have been shown
to correlate with a higher risk of mortality and complications after a heart attack in women. Women have been
disproportionally affected by the psychological effects of this pandemic. Therefore, it is critical to investigate the
molecular pathways underlying the stress response, depression, and cardiovascular disease. The present
proposal aims to test if increases in the primary stress hormones glucocorticoids inhibit estrogen protection in
the female heart by altering the reductive/oxidative state in cardiomyocytes. To accomplish this goal, we propose
identifying the mechanism whereby stress downregulates the activation of the cyclin-dependent kinase inhibitor
1A (Cdkn1A or p21) and the nuclear factor erythroid-2-related factor 2 (Nrf2) signaling in cardiomyocytes and
the whole heart. The p21-Nrf2 signaling pathway is essential to limit oxidative stress damage in
hypoxia/reperfusion injury in vitro. We will investigate if the activation of the glucocorticoid receptor (GR) by
restraining stress (model of mental stress which leads to a phenotype that mimics depression in humans) inhibits
the estrogen receptor (ER)-mediated activation of the p21-Nrf2 signaling pathway in the context of
hypoxia/reoxygenation. Using a transgenic mouse model lacking the GR in the heart, we will investigate if the
activation of this stress receptor to changes in cardiac reductive/oxidative balance in response to
ischemia/reperfusion (I/R) injury in female hearts by altering estrogen signaling. We will also test if restoring p21
expression (AAV delivery approach) in female hearts improves the cardiac outcomes after stress by reducing
the production of reactive oxygen species. If funded, this project will provide critical knowledge on the cardiac
consequences of stress and depression at the physiological and molecular level for the female heart. Also, the
data gathered from the experiments described in this grant will promote the importance of sex as a factor to
consider when considering antioxidant therapies in heart disease and failure.